Improving WIC Services: Identifying Children at Risk for Obesity in the First 24 Months of Life

PROJECT SUMMARY/ABSTRACT
Children in low-income families and who are racial/ethnic minorities are disproportionately affected by risk
factors for obesity in the first 24 months of life, such as lower rates of exclusive breastfeeding and higher rates
of food insecurity. Reaching over 7 million low-income, racially diverse participants, the Special Supplemental
Nutrition Program for Women, Infants, and Children (WIC) is in an important position to improve dietary
patterns in early childhood, a critical developmental period for establishing lifelong eating habits. A federal
requirement of WIC is to identify nutritional risk of children and provide nutrition education to all low-income
families served by the program. The effectiveness of this counseling is directly related to the effectiveness of
nutrition screening measures. Currently, WIC programs around the country use nutrition questionnaires to
assess nutrition risk of all infants and young children and use results to determine counseling services based
on these assessments. Few of these questionnaires are validated, however, and none have proven predictive
validity to identify obesity and diet quality at 24 months of age. Our long-term goal is to identify effective dietary
strategies to prevent obesity and reduce disparities in low-income infants and toddlers. The overall objective of
this proposed study is to better understand how diet patterns during a critical time period during infancy are
associated with risk for obesity in the first 24 months of life. This work is relevant to my K01 award because my
research with school-aged children has led me to identify ways to improve nutrition earlier in life. Children as
early as 24 months have already established dietary habits that can impact long-term weight and health. We
will use data from the first-ever national cohort of WIC-enrolled children followed longitudinally from ages 0 to
24 months in the USDA’s WIC Infant and Toddler Feeding Practices Study-2 (WIC ITFPS-2). WIC ITFPS-2
collects extensive data on diet, feeding behaviors, and anthropometry from the largest, most diverse cohort of
WIC participants studied to date. Finally, this study will provide the preliminary evidence for a R01 proposal to
conduct a randomized controlled trial to test if targeting nutritionally at-risk infants for more specific WIC
nutrition education services compared to providing standard education services reduces obesity disparities in a
low-income population.

Public health relevance
PROJECT NARRATIVE Despite the benefits of early nutrition, few studies have examined the diets of young children from low-income households, who are particularly vulnerable to food insecurity and poor diet quality. Currently, WIC programs around the country use nutrition questionnaires to assess nutrition risk of all infants and young children and use results to determine counseling services based on these assessments, however, none have proven predictive validity to identify obesity and diet quality at 24 months of age. The proposed research is relevant to public health because it has the potential to allow WIC practitioners to identify early dietary risk factors to childhood overweight and help caregivers modify behaviors in the first two years of life.